Determinants of Early Childhood Immune Responses

Abstract
Vaccination strategies for SARS-CoV-2 in young children have not yet fully incorporated their unique
immunologic profiles to ensure effective and durable protection. Children often present with milder SARS-CoV-
2 disease than adults but remain at risk for acute COVID-19 and multisystem inflammatory syndrome in
children (MIS-C). Roll out of SARS-CoV-2 vaccination was markedly delayed in younger age groups, therefore
many young children have been infected with SARS-CoV-2 prior to vaccination. It is currently unknown if
young children with prior SARS-CoV-2 infection have differential responses to SARS-CoV-2 vaccination
compared to SARS-CoV-2 naïve children and if there is an optimal timing interval to increase durability of
protection. From in utero to early childhood to adulthood there is a gradual shift in immune responses from
tolerogenic to immunogenic. Infants have attenuated T and B cell responses to some vaccines compared to
adults, and often need multiple doses of primary vaccine series. We will leverage a highly-detailed cohort of
young children aged 6 months to 4 years old receiving early childhood SARS-CoV-2 immunization. We will use
high-dimensional antibody profiling and flow cytometry to perform a detailed characterization of SARS-CoV-2
vaccine-specific immune responses in young children. We hypothesize young children with prior SARS-CoV-2
infection will have more robust and durable SARS-CoV-2 specific cellular and antibody responses to SARS-
CoV-2 vaccination compared to previously uninfected. During the first year of life, maternally-derived
antibodies (MatAbs) are present in infants and provide partial protection against pathogens during this period
of immunologic vulnerability. However, the presence of MatAbs at the time of immunization in infants have
been shown to inhibit vaccine responses regardless of vaccination type or platform. Numerous mechanisms
have been proposed for this inhibition by MatAbs, including neutralization of vaccine antigen, epitope masking
of immunogenic epitopes, or differential Fc function and engagement of inhibitory receptors. Though it is
currently unknown if SARS-CoV-2 MatAbs impact infant immune responses. We hypothesize that the MatAbs
repertoire will preferentially contain neutralizing antibodies with persistence of SARS-CoV-2 epitope-specific
antibodies that will mask SARS-CoV-2 vaccine-specific responses in infants. Together these studies will
provide needed insight on SARS-CoV-2 vaccine-specific and hybrid immunity to optimize timing of primary
vaccination series including after SARS-CoV-2 infection and potential boosting for young children. Additionally,
detailed studies of the characterization and persistence of SARS-CoV-2 MatAbs repertoires will allow new
insights into mechanisms underlying protection against SARS-CoV-2 in early infancy and potential inhibition of
vaccine responses.

Public health relevance
Project Narrative Detailed studies on the unique age-specific cellular and functional antibody profiles and the impact of pre- existing immunity on SARS-CoV-2 vaccine-specific responses are needed to maximize protective responses, durability, and inform potential future boosting strategies for young children. Our objective is to determine the impact of pre-existing immunity from either prior SARS-CoV-2 infection or the presence of passively-derived maternal antibodies on SARS-CoV-2 vaccine-specific immune responses to determine optimal timing of SARS- CoV-2 vaccines in early childhood.